UConn Undergraduate Training Program for Maximizing Access to Research Careers

Project Summary N/A. Form included to avoid Grants.gov Submission Errors.

Public health relevance
Project Narrative N/A. Form included to avoid Grants.gov Submission Errors.